Discovery and Characterization of Novel Sepsis Proteome Biomarkers

ABSTRACT
This project will use mass spectrometry-based proteomics for biomarker discovery and validation and will
perform early evaluation of strong candidate biomarkers and biomarker signatures that might form the foundation
for new clinical blood tests. These biomarkers can be used as diagnostic tools for early detection of sepsis and/or
facilitate the clinical development of sepsis therapeutics.
Objectives: The focus of this application is on the identification and initial biological, analytical and clinical
evaluation of biomarkers and biomarker signatures for sepsis that will be ready for definitive analytical and clinical
validation.
Central hypothesis: Discovery proteomics using blood samples from well-standardized non-human primate
sepsis models followed by validation in clinical samples has the potential to reveal new biomarker and biomarker
panels for early detection, prognosis and therapy monitoring of sepsis patients.
Rationale: Sepsis is a complex, heterogeneous disease that frequently is complicated with comorbidities (e.g.,
cancer, diabetes, cardiovascular disease) that can alter the host responses to pathogens, thus making it difficult
to determine the spectrum of sepsis-specific biomarkers by discovery proteomics in clinical plasma samples. We
propose to use unbiased proteomics, coupled with robust bioinformatics to discover novel predictive biomarkers.
We are in a unique position to achieve these goals, having access to well-characterized plasma samples from
historical time-course experiments using baboon models of Gram-negative or Gram-positive bacteremia –
coupled with access to a NIGMS national proteomics resource equipped with world-class instrumentation and
expertise. Further, quantitative proteomics and immunoassays will be used for qualification and validation of the
novel biomarkers in human plasma from sepsis patients.
Specific Aim 1: Identification and organ mapping of early stage biomarkers during the time course of
experimental sepsis in baboons.
Specific Aim 2: Validation and performance testing of biomarker candidates in clinical samples.
Impact: Our short-term goals are to identify biomarkers and biomarker signatures for sepsis in baboons and
perform the initial biological, analytical and clinical evaluation in humans using carefully standardized samples
and datasets. The long-term goal of our project is to deliver novel candidate biomarkers that are ready for
definitive analytical and clinical validation studies. These biomarkers will allow early diagnosis and monitoring of
sepsis progression and will help patient stratification for targeted therapies.

Public health relevance
PROJECT NARRATIVE Relevance to public health: Sepsis is a common and serious clinical condition and the number one killer of hospitalized patients. Early detection and treatment are crucially important for an improved outcome, therefore there is an acute need for accurate biomarkers for early diagnosis, prognosis and guiding therapy. Relevance to the NIGMS mission: Identification, characterization, and validation of sepsis-specific biomarkers particularly in the context of enabling endotyping strategies or future evaluation of diagnostics and novel therapies is one of NIGMS priorities on sepsis research (NOT-GM-19-054).